Unraveling the molecular interconnections between circadian rhythms and lipid metabolism

PROJECT SUMMARY
Circadian clocks drive the 24-hour rhythms regulating many aspects of metabolism whereas metabolic activities modulate
the clock function. Dysfunction of the clock is associated with metabolic disorders, compromising organismal response to
the environment. However, the molecular interplay between metabolism and the clock and, in particular, the
mechanism by which metabolism affects clock functions are not well understood. Recent studies indicate that
phosphatidic acid (PA), a central lipid metabolic intermediate and important lipid messenger, interacts with the core clock
transcription factors LATE ELONGATED HYPOCOTYL (LHY) and CIRCADIAN CLOCK ASSOCIATED 1 (CCA1),
and genetic and chemical manipulations of PA levels alter the clock functions in Arabidopsis. PA and its production
enzymes, phospholipase D (PLD) and diacylglycerol (DAG) kinase (DGK), affect various cellular and pathophysiological
processes in humans and other organisms. These findings suggest that specific lipid-clock factor interactions may act as a
molecular conduit to integrate metabolic and clock activities. They further indicate that PA signaling acts in nuclei, affecting
critical nuclear processes, but its cellular actions have been studied primarily outside the nucleus. Thus, this research aims
to fill three key knowledge gaps: 1) how PA mediates nuclear processes; 2) how PA and lipid metabolism modulate
the clock; and 3) how the molecular clock regulates lipid metabolism, by addressing several interlaced questions and
challenges: What are the subnuclear locations of PA-protein interactions, the effect of PA on stress-induced DNA repair
and transcription, the lipid-clock interactome, and the impact of clock perturbations on specific lipid metabolic processes?
Additionally, how do lipid-clock interplays affect stress responses? Could the lipid-clock interplay be modulated to improve
organismal resilience to adverse environments and lipid production? These questions will be approached by integrating
multiple open-ended and targeted strategies, including lipid imaging in vivo, subcellular lipidomics, lipid-protein
interactome, multiplex genomic editing, non-invasive phenotyping, and deploying extensive genetic and analytical
resources developed in the model organism Arabidopsis. The mechanistic study of PA’s action in nuclei will advance the
understanding of the emerging lipid mediator PA, such as its role in mitogenesis and stress responses. Unraveling the
molecular interplays between the clock and lipids will elucidate the mechanism by which lipid metabolic malfunctions
perturb the clock function and, conversely, clock disruptions lead to metabolic dysfunctions. In addition, the study will
advance the functional understanding of PLD and DGK and have potential applications to improve plant resilience to
environmental stress and lipid production. Because the basic molecular mechanism of the clock is conserved between plants
and humans, and the molecular clock, PA, and its production enzymes play important roles in pathophysiological process,
the findings from this research have significant relevance to public health.

Public health relevance
PROJECT NARRATIVE The proposed research aims to fill critical knowledge gaps to understand the molecular interconnection between lipid metabolism and circadian clock, and the mechanism of phosphatidic acid signaling in nuclei. The results will advance fundamental knowledge underlying the molecular and signaling mechanisms that regulate lipid metabolism, clock function, and stress responses. This work will provide novel insights into the molecular process leading to metabolic and physiological dysfunctions associated with disrupted lipid metabolism and clock functions. This outcome is relevant to the part of NIGMS’s mission that fosters fundamental discoveries and innovative research strategies as a basis for ultimately improving human health.